Novel Assessments of the Health Impacts of Tropical Cyclones

PROJECT SUMMARY/ABSTRACT
In the United States, tropical cyclones, such as hurricanes and tropical storms, have a devastating impact on
society. However, beyond some limited studies, there remains a critical research gap in understanding the full
extent of the impact of tropical cyclones on health. The objective of this K99/R00 application is to ﬁll this research
gap with several novel assessments of the health impacts of tropical cyclones. To be able to fulﬁl this objective,
this K99/R00 application is interdisciplinary, involving the collaboration of experts in environmental epidemiology,
exposure assessment, Bayesian statistics, machine learning, computer vision, and social epidemiology. The K99
phase is designed to augment the candidate's prior research experience through coursework, mentorship, and
directed readings, with speciﬁc training in (1) climate-related disaster epidemiology and exposure assessment;
(2) advanced Bayesian statistics methodology; (3) machine learning and computer vision for public health; and
(4) social epidemiology in a disaster and public health context. The skills gained during this award are critical to
the candidate's long-term goal to become a leading and methodologically strong environmental epidemiologist
who conducts rigorous large-scale research that contributes to society's understanding of tropical cyclones and
other environmental hazards to help inform policies in the United States and worldwide. The proposed project
will draw on rich data sources on hospitalization (Medicare and Medicaid cohorts); death (National Center for
Health Statistics); tropical cyclone exposure; and satellite- and ground-based imagery, all of which span several
recent decades and cover all of the United States exposed to tropical cyclones. Aim 1 (K99 phase) will improve
and harmonize estimation of excess hospitalizations and deaths after each named hurricane by (a) applying
an ensemble of Bayesian models to hospitalization and mortality data to estimate weekly hospitalization and
deaths rates that would have been expected had hurricane exposure not occurred; then (b) comparing the actual
historical hospitalization and death rates to calculate excess hospitalizations and deaths. Aim 2 (R00 phase)
will (a) determine the impact of repeated tropical cyclone exposure on chronic health outcomes by analyzing
the association between tropical cyclone exposure and monthly hospitalizations or deaths by applying Bayesian
spatio-temporal hazard models; then (b) accurately forecast health impacts by using results. Aim 3 (R00 phase)
will characterize how physical neighborhood features explain differences in health impacts of tropical cyclones by
(a) utilizing machine learning and computer vision techniques to identify various physical neighborhood features in
tropical cyclone-exposed areas using satellite and street-level imagery; then (b) converting features into metrics in
health models to investigate if and how health impacts of tropical cyclones vary by those metrics. The proposed
training and research program both closely align with NIEHS's mission and Strategic Plan, and is responsive
to NIEHS's priorities of Data Science and Big Data (Theme I, Goal 7), Environmental Health Disparities and
Environmental Justice (Theme II, Goal 4), and Emerging Environmental Health Issues (Theme II, Goal 5).

Public health relevance
PROJECT NARRATIVE In the United States, tropical cyclones, such as hurricanes and tropical storms, have a devastating effect on society, yet a comprehensive assessment of their health impacts is still lacking. The proposed research is relevant to public health because it focuses on quantifying the hospitalization and mortality burden of tropical cyclones while also characterizing physical factors that drive differences in impacts on vulnerable communities. The results of this project are expected to greatly beneﬁt understanding of the health impacts of tropical cyclone exposure, and create actionable results that identify the most vulnerable communities, closely aligned with NIEHS's mission and Strategic Plan.